Glutarate metabolism in Salmonella

PROJECT SUMMARY
Infection with the bacterial pathogen Salmonella enterica serovar Typhimurium (S. Tm)
is a common cause of inflammatory diarrhea. Intriguingly, intestinal inflammation drives
an expansion of the S. Tm population in the gut lumen. The molecular mechanisms that
support S. Tm colonization of the intestinal tract remain incompletely understood. Our
central hypothesis is that the inflamed gut constitutes a peculiar nutritional environment
that enables S. Tm to outgrow obligate anaerobic commensal bacteria. In this
application, we will investigate how inflammatory reactive oxygen and nitrogen species
are generating a diverse array of inflammation-associated small metabolites. We
hypothesize that reactive oxygen and nitrogen species oxidize sugars to smaller mono-
and dicarboxylic acids such as glutarate, which serve as nutrients for S. Tm to support
gut colonization. We will test key aspects of our hypothesis in mouse models of infection
and in vitro. We will pursue the following specific aims: 1.) Determine whether glutarate
and other carboxylic acids are generated as byproducts of RNS metabolism, and 2.
Investigate S. Tm glutarate metabolism in the context of infection. This work will advance
our understanding of how intestinal pathogens, such as S. Tm, adapt their carbon and
energy metabolism to colonize the mammalian intestinal tract. These studies are also
expected to advance our understanding of how reactive oxygen and nitrogen species
participate in diversity-generating reactions that shape the metabolite landscape during
gut inflammation.

Public health relevance
PROJECT NARRATIVE Non-typhoidal Salmonella serotypes are a common cause diarrheal disease in the United States, with a cost of $0.5 to $2.3 billion per year due to lost productivity and the cost of medical care. This application will support studies on how Salmonella colonizes the mammalian intestinal tract. A better understanding of the metabolism of bacterial pathogens is expected to aid in the development of new intervention strategies.